Autophagy and Protein Degradation in Parkinson's Disease Models

DESCRIPTION (provided by applicant): Several observations have linked neurodegenerative disorders such as Parkinson's disease (PD) and Alzheimer's disease with altered intracellular protein degradation (1). Recently, autophagy mechanisms leading to lysosomal-mediated protein degradation have come into focus. Autophagy is an essential mechanism of protein degradation that is induced in the context of starvation and other stressors, and is a prominent feature in brain pathology in neurodegenerative diseases (3, 4), likely representing defects in the autophagy-lysosome pathway (5). Furthermore, mutations in lysosomal genes have been found to underlie rare familial inherited forms of Parkinsonism (6) and associated with common sporadic PD(3). Key questions exist: i. Do autophagy defects recapitulate aspects of neurodegenerative disorders? ii. By what mechanism does altered autophagy in mDNs lead to pathological and morphological changes? We hypothesize, based on preliminary data, that: i. Autophagy plays a central role in regulating the survival and morphology of mDNs, and deficiency of autophagy recapitulates key aspects of neurodegenerative pathology, including accumulation of disease-associated proteins. ii. A novel mechanism by which autophagy defects lead to pathology is through direct (but non- canonical) downstream modification of the PI3K/PTEN/AKT/GSK3beta/Tau signaling pathway;this relates specifically to altered accumulation of signaling pathway components. iii. The altered PI3K/PTEN/AKT/GSK3beta/Tau pathway signaling plays a causal role in the phenotypes associated with autophagy deficiency. PUBLIC HEALTH RELEVANCE: Several observations have linked Parkinson<s disease (PD) with altered intracellular protein degradation. Here we investigate the role of autophagy, a mechanism of protein degradation, in neuron survival and function in the context of PD models, and we relate autophagy to a key cellular signaling mechanism. We propose to identify novel potential therapeutics for PD that function in this pathway.

Public health relevance
Several observations have linked Parkinson’s disease (PD) with altered intracellular protein degradation. Here we investigate the role of autophagy, a mechanism of protein degradation, in neuron survival and function in the context of PD models, and we relate autophagy to a key cellular signaling mechanism. We propose to identify novel potential therapeutics for PD that function in this pathway.